TRANSFER Neural Underpinnings of Emotion Regulation and Drinking to Cope among Problem Alcohol Drinkers

Project Summary/Abstract
This Mentored Patient-Oriented Research Career Development application (K23) will provide protected time for
Dr. Pilar Sanjuan to develop a focused program of experimental alcohol research and its application to the
study of neural mechanisms of emotion regulation underlying alcohol problems. The aims of the 5-year career
development plan are tightly integrated and will increase her knowledge and experience in the areas of 1)
collecting and analyzing objective neural (fMRI) and psychophysiological emotion regulation data, 2) utilizing
advanced quantitative analysis and ecological momentary assessment (EMA) technology for real-time
collection of longitudinal data in the field, and 3) grant writing and professional development. The career
development plan includes structured meetings with mentors; five graduate level courses in neuroscience,
cognitive psychology, and bioethics; and relevant conferences and workshops to develop substantive expertise
and training in quantitative/research methods and uses of statistical software. Specific plans are described to
consolidate knowledge gains associated with the career development aims through secondary analyses of
extant fMRI and EMA data sets. These activities will culminate in the development of an R01 proposal using
preliminary data from the associated study in the third and fourth years of the funding period, thus facilitating
the transition of Dr. Sanjuan from clinical psychologist to independent neuroscientist. The proposed study will
have 3 components and is sequenced to support career development aims: (1) a laboratory-based design to
identify emotion regulation and craving neural networks associated with subjective distress and
psychophysiological reactivity during emotion regulation in problem drinkers, (2) a field-based design using
EMA to determine the relationship of problem drinking with subjective distress, alcohol craving, and drinking to
cope, and (3) a lab-to-field analysis to assess the efficacy of laboratory-based neural activation to predict real
life craving and drinking to cope measured via EMA. fMRI and psychophysiological assessments will be used
to examine neural underpinnings of emotion regulation and EMA methods will be used to examine the real life
emotion regulation to drinking to cope relationship. Dr. Eric Claus will be primary mentor and has recognized
expertise in cognitive neuroscience, especially alcohol-related neuroimaging. Drs. J. Scott Tonigan and James
Gross will serve as secondary mentors supporting the candidate in selected areas including laboratory study of
emotion regulation, grant writing, human subjects protections, and data analysis. Drs. Marsha Bates and
Matthew Pearson will serve as consultants to assist Dr. Sanjuan to consolidate knowledge gains in applying
psychophysiology and EMA methods and analyses in the context of alcohol research.

Public health relevance
Public Health Relevance Many individuals who seek and enter treatment continue to drink and suffer from alcohol problems despite their efforts to change. Understanding the underlying neural processes of people with alcohol problems who are unable regulate their emotional responses to negative moods and how this relates to daily alcohol use will allow us to apply this knowledge to help patients with similar problems to recover. This training program will train the investigator in the best methods to see how brain activity measured in the laboratory is related to day- to-day stress and drinking among people with drinking problems.